IGF::OT::IGF:THE SCRIPPS RESEARCH INSTITUTE. TASK ORDER 2 (HHSN275201500006I/HHSN27500002)."PRODUCTION AND DISTRIBUTION OF INVESTIGATIONAL GHRELIN VACCINES--GHRELIN VACCINE AGAINST RAT HORMONE. 09/21/

Alcohol (get abstract from HD)